Core A Administration

Administrative Core A of this Program project will provide oversight of organizational aspects, including scientific leadership through the Directors, Dr. Xandra Breakefield and Dr. E. Antonio Chiocca, with administrative expertise provided by Ms. Robin Sobolewski. This core will be responsible for assuring the ethical conduct of all scientific investigations including decision-making regarding thematic and personnel changes, and rigor and reproducibility of scientific and clinical data according to NIH guidelines. Other functions of the core include: 1) organization of scientific meetings among investigators, both within this multi- institutional Program Project (MGH, BWH, UCSD and Tufts), including meetings and oversight by the External Advisory Board and Steering Committee, as well as monthly investigator reviews and annual external reviews and with collaborators; 2) facilitation of EV correlative biomarker collaborative studies in support of clinical trials; 3) oversight of data sharing and pre-publication review; 4) programmatic integration to insure synergies, investigator interactions, and timely completion of studies; and 5) transparent and authorized financial conduct.

Public health relevance
This Core A will ensure organizational and scientific oversight to the Program project, including active participation and synergy, decision making and financial surety.